Consequences and Control of Randomness in Timing of Intracellular Events

An Abstract is not required for this administrative supplement request for award # R01GM124446.

Public health relevance
A Narrative is not required for this administrative supplement request for award # R01GM124446.